PAGE II genotyping at CIDR

Population Architecture using Genomics and Epidemiology (PAGE) is an NHGRI‐funded consortium that aims to examine the population architecture of complex traits, using broad and deep phenotype data from existing and ethnically diverse cohorts. Previously in Phase I (2008‐2013), PAGE performed targeted genotyping of SNPs identified from genome‐wide association studies (GWAS) in ~100,000 European and non‐European descent populations and dense Metabochip genotyping in ~ 60,000 African American, Hispanic/Latino, Asian, and Native Hawaiian participants. The finer level of genotype resolution from Metabochip genotyping facilitated ethnic-specific fine mapping of a wide range of metabolic and cardiovascular traits.